Administrative Core

Delaware Center for Neuroscience Research
Administrative Core
The role of the administrative core will be to coordinate resources,
expertise and programs across Delaware State University and the University of
Delaware to support the continued success of the Delaware Center for
Neuroscience Research. The focus of the Administrative Core is to build and
sustain a community of researchers across Delaware who are investigating the dynamic functions of the
brain and nervous system, and to grow the number of investigators at our institutions who are competitive
for external funding for their research. The Administrative Core is centered at Delaware State University
with a subcore at the University of Delaware to ensure coordination of efforts at both institutions. The
Administrative Core will provide the oversight necessary for continued success of the Delaware Center for
Neuroscience Research during COBRE Phase III and then to ensure the long-term sustainability of the
Center beyond the Phase III award.
The Center Director, Dr. Melissa Harrington, will continue to lead the Administrative Core and Dr.
Jeffrey Rosen will initially continue to act as the director for the University of Delaware. Dr. Anna
Klintsova, an R01-funded graduate of our Phase I COBRE award will be joining the leadership team as a
co-director for the UD subcore. This addition is part of succession planning for the project as Dr. Rosen
will retire during the term of the Phase III award. An internal advisory committee of graduated investigators
from earlier phases of the Center and veteran research core directors will help guide the investigator
development plan and maturation of the cores toward long term sustainability
Our Neuroscience Center brings together a multidisciplinary group of neuroscientists at DSU and
the University of Delaware to take part in Center-sponsored meetings, retreats, symposia and professional
development activities. The administrative core personnel, the PI, the UD Director and co-director, and the
Program Coordinator, with the assistance of the Internal Advisory Committee will coordinate and oversee
the annual symposium, mock study sections, the research retreats and other professional development
activities of the Center.
The PI and the administrative core will be responsible for evaluating the performance of Center
constituents, including the performance of the cores, the productivity of the pilot investigators and the
overall impact of the Center. The Admin Core will also be responsible for annual reporting to NIGMS and
to various internal constituencies. In addition, as NIGMS has increased its investments in IDeA programs
through administrative supplements applications for supplemental funding are of increasing importance. In
phase III the Admin Core will also have a focus on ensuring that Neuroscience Center teams submit
applications for all of the administrative supplements for which we are eligible.

Public health relevance
Delaware Center for Neuroscience Research Public Health Relevance Summary The foundation of Phase III proposal is Delaware’s expanding set of human and research resources in neuroscience, which has Delaware neuroscience research competitive on a national level. Our project supports research aimed at determining how thoughts, memories, feelings and actions emerge from dynamic activities in the brain and are changed over time; as well educational programs to develop a workforce that can participate in and benefit from advances in our understanding of brain function. An increased understanding of how the brain and nervous system functions will facilitate treatments for diseases and injuries and provide insights into human behavior, biases, and cognition.